Superior Colliculus Pathways for Defensive Behavior and Emotional Arousal

ABSTRACT
Alterations in brain circuits underlying defensive behavior are thought to substantially contribute to the
dysfunction present in anxiety disorders, which frequently emerge in adolescence, affect roughly one in three
individuals in their lifetime, and are a leading cause of health burden globally. Research in nonhuman animal
models shows that defensive responses to threats are mediated by multiple subcortical pathways involving the
superior colliculus, and human neuroimaging studies show that functional alterations in the colliculus-pulvinar-
amygdala pathway are present in individuals with post-traumatic stress disorder and anxiety. However, it is
presently unclear how the human superior colliculus contributes to fear and anxiety, whether by participating in
subcortical circuits that coordinate defensive behavior, or via pathways to cortical systems involved in spatial
attention, emotional arousal, and emotional experience more broadly. The long-term goal of the proposed
research is to develop a mechanistic understanding of human superior colliculus pathways across domains of
function relevant to mental health. Here we aim to characterize its contribution to defensive behavior and
emotional experience across multiple tasks in a community-based functional magnetic resonance imaging
study and using data from the Adolescent Brain Cognitive Development Study. Aim 1 evaluates the
functional specificity of superior colliculus pathways, using machine learning techniques to model
pathway connectivity as individuals perform tasks involving probabilistic avoidance learning, spatial attention,
and naturalistic aversive experience concurrent with fMRI. The functional relevance of each pathway will be
established by examining correlations between pathway activation and task-relevant behavior. Aim 2
identifies how looming threat is encoded in the human superior colliculus, its connectivity with cortical
systems, and its relationship with subjective experience. We will use computational neuroimaging approaches
to evaluate whether fMRI signal in the superior colliculus is better explained by encoding models that capture
dynamic or static representations of threat and characterize how representations of threat encoded in the
superior colliculus covary with activity in cortical systems and self-reported experience. Aim 3 will determine
the relationship between individual differences in frontal-superior colliculus pathway activity and
anxiety symptoms during adolescence. We will test the hypothesis that cortical pathways to the superior
colliculus attenuate responses to threat cues and are negatively associated with individual differences in
anxiety using data from the Adolescent Brain Cognitive Development Study. Completing these aims will
provide foundational knowledge of how the superior colliculus is involved in defensive behavior, subjective
fear, and emotional arousal, and the degree to which alterations in specific pathways are related to anxiety. We
expect that findings from this research will provide insights into the brain mechanisms underlying anxiety
disorders and facilitate translational efforts across species and into clinical settings.

Public health relevance
PROJECT NARRATIVE Responses to looming danger, ranging from threat assessment to active avoidance, are critical for survival and well-being. This project leverages pattern recognition techniques to develop models of cortical and subcortical brain pathways involving the superior colliculus to understand their roles in defensive behavior and emotional experience, and how they mature during adolescence. The knowledge generated by this research can inform mechanistic models of emotion processing and may ultimately lead to the development of improved targets for therapeutic interventions.